Differential Spatial cAMP Signaling in the Pancreatic Beta cell

PROJECT SUMMARY/ABSTRACT
Cyclic adenosine monophosphate (cAMP) is a key signaling molecule that is essential for pancreatic beta-
cell gene expression, function, and survival. Recent studies indicate that the cellular response to cAMP signaling
varies based on the location within the cell where cAMP is generated.
Important targets of diabetes therapy are G-protein coupled incretin hormone receptors located on beta-cells.
Upon ligand binding on the cell surface, the incretin hormone receptors glucagon like peptide-1 (GLP-1R),
glucagon (GCGR), and glucose dependent insulinotropic peptide (GIPR) activate the G-protein Gas-to stimulate
cAMP synthesis at the inner surface of the cytoplasmic membrane. Furthermore, these ligand-bound receptors
are internalized into early endosomes within the cell body, from where they continue to generate cAMP before
recycling to the cell surface or before being degraded through the ubiquitination pathway.
Although incretin hormone receptor agonists are central to diabetes treatment and generate cAMP from
different locations within the beta-cell, very little is understood about the differential role of cAMP signaling events
that originate from different intracellular compartments. Furthermore, therapeutic incretin receptor agonists are
designed to potentiate insulin secretion, while their effects on beta-cell gene expression remain poorly defined.
Based on our preliminary studies, we hypothesize that the beta-cell differentially interprets cAMP signaling
based on the spatial location of cAMP synthesis. We hypothesize that incretin hormone GPCR-stimulated cAMP
signaling from the cell surface predominantly potentiates glucose-stimulated insulin secretion (GSIS) with little
effects on gene expression in the nucleus. Conversely, cAMP generated at endosomes has minimal effects on
GSIS potentiation, but potently regulates cAMP-dependent gene expression in the nucleus. We also find that in
mice that are fed a diabetogenic diet, incretin hormones retain their ability to potentiate GSIS (cAMP from the
plasma membrane) but lose their ability to regulate beta-cell gene expression (cAMP from the endosome). Thus,
beta-cell endosomal cAMP signaling is defective early in diabetes pathogenesis, thereby leading to altered gene
expression.
We now seek to expand our novel and exciting findings specifically a) to understand the differential roles of
cAMP generated from different cellular locations in regulating beta-cell function and gene expression; b) to
understand the consequences of selective disruption of endosome-derived cAMP signaling on beta-cell function
and gene expression
Our studies will yield important and fundamental insights into the role of cAMP signaling in beta-cell biology.
Furthermore, our studies have the potential to identify new molecular mechanisms that can be targeted in order
to prevent and/or reverse the relentlessly progressive beta-cell deterioration in diabetes mellitus.

Public health relevance
PROJECT NARRATIVE Cyclic AMP (cAMP) signaling regulates important pathways governing pancreatic beta cell function and gene expression. This proposal advances initial observations that within the pancreatic beta cell, the cellular location where cAMP is generated differentially regulates beta cell function versus gene expression.